DEVELOPMENT OF MEMBRANE GLYCOPROTEIN STRUCTURE

The long-range objectives of this study are to understand the manner in which folding information is encoded in the primary sequence of membrane proteins and the means by which the cell recognizes when this process of information transfer has failed. The studies of the cystic fibrosis transmembrane conductance regulator (CFTR) supported by this grant entering its fourth year, have provided fundamental information relevant to understanding the nature of the AF508 folding mutant responsible for most cases of cystic fibrosis and the proteins which transiently interact with CFTR to assist efficient folding. Future studies will focus on elucidation of the conformation of critical folding intermediates, the machinery that recognizes these intermediates, and the later steps in folding, namely the association of CFTR with other proteins to form macromolecular complexes at the membrane. To this end the five specific aims are to: 1. Characterize the structure of the CFTR foldina intermediate altered bv the AF508 mutation. Established biophysical methods will be employed to characterize the structural features of the critical folding intermediate. 2. Identify the protein machinery required for recognition of the folding intermediate and characterize their mechanism of action. The proteins required for recognition of the critical folding intermediate in vivo will be isolated using our recently developed in vitro proteolysis assay which distinguishes mutant from wild type protein during folding. 3. Determine the folding pathway of the first transmembrane domain of CFTR and the effect of disease-causing mutations. Peptide models of the transmembrane spans of CFTR and an in vitro translation system will be utilized to study the membrane-integration and helical-association steps of the wild type and mutant transmembrane domains. 4. Identity the proteins that recognize misfolded transmembrane domains and determine their mechanism of action. Site specific-crosslinking and high stringency immunoprecipitations will be used to identify proteins that interact with misfolded mutant transmembrane domains of CFTR. 5. Characterize the interaction of CFTR with other proteins during maturation to form a supramolecular complex. Based on our recent finding that CFTR activates the anion exhanger in CFTR expressing cells and tissues, we will test the hypothesis that these proteins associate to form a large quartemary structure during the last steps of folding. To accomplish these goals, a combination of biochemical, biophysical, immunochemical, molecular and cell biological approaches, all established in this laboratory, will be employed. These studies are necessary for and fundamental to a detailed understanding of the mechanisms by which membrane proteins fold.